Shared Equipment & Facilities Module

Bascom Palmer Eye Institute is a comprehensive, disease-focused academic unit that serves as the Department Of Ophthalmology, for the University of Miami Miller School of Medicine. The Anne Bates Leach Eye Hospital is Bascom Palmer's main facility for ophthalmic care. The adjacent Evelyn F. and William L. McKnight Vision Research Center (MVRC) is Bascom Palmer's research arm, and also coordinates all aspects of Bascom Palmer's research mission. Moreover, MVRC draws together NEI-funded eye and vision research investigators across the University of Miami and nearby institutions as the Miami Eye Team. This P30 core center grant application is specifically directed towards this group of investigators to share in research activities, collaborative expertise, core resources, and educational programs. The long-term goal of this P30 proposal is to strengthen the conceptual and methodological capabilities of Miami Eye Team investigators, thus expanding and enhancing their contributions to knowledge and understanding of the eye, vision, and blinding eye diseases. We request continued funding of the P30EY014801 Core Grant for Vision Research to support the following core resource modules: (1) Shared Equipment, (2) Experimental Models, (3) Biological Imaging, (4) Biostatistics. Biological Imaging combines two previous modules ?Histology & Tissue Processing and Analytical Imaging? because of their methodological interrelatedness.